Learn-As-you-GO (LAGO): An innovative adaptive design for multi-component intervention studies in cardiology and public health

The use of complex, multi-component interventions (CMCIs) is an increasingly important aspect of
cardiovascular disease prevention, screening, and treatment. For example, this application’s co-Investigator
Longenecker is the principal investigator of a CMCI trial nearing completion aimed at improving blood pressure
control, EXTRA-CVD (XCVD), consisting of 4 components: 1. Nurse-led care coordination, 2. Nurse-managed
medication protocols and adherence counseling 3. Home blood pressure (BP) monitoring, and 4. Electronic
health record (EHR) support tools, to be compared with generic prevention education. Each component has a
“dose”, e.g. number of days/week home BP should be recorded and reported, and number and duration of
adherence counseling sessions. Implementation scientists, such as those conducting this trial, discuss the
tension between fidelity to the original intervention protocol, and the need for tailoring, tweaking and
adaptation, perhaps contextually driven, i.e. varying by facility size, composition of the provider workforce, or
health status of the patient population served. Under our innovative Learn-As-you-GO (LAGO) design, as the
trial evolves, the doses of these intervention components are adapted at pre-specified stages to maximize
cost-effectiveness and reduce the ultimate risk of trial failure by achieving pre-specified statistical power, while
at the same time preserving the nominal size of the hypothesis test for the overall intervention package effect
and attaining a pre-planned study outcome goal, such as attainment of 80% of patients under blood pressure
control. Because each intervention component is associated with different costs and effectiveness, it is difficult
to specify the optimal intervention package, that is, the optimal intervention component “doses” along with the
components themselves, before launching a trial, as standard methods require. LAGO designs for continuous
outcomes, such as changes in blood pressure (mmHg) or cholesterol levels (mg/dL) as in XCVD; for repeated
binary outcomes, such as per visit hypertension control; and which account for clustering of outcome rates
within centers are not available. In this project, following on our 2021 Annals of Statistics publication
establishing fundaments for logistic regression analysis of a single binary outcome in non-clustered data, we
will derive the mathematical theory for LAGO designs for clustered binary and continuous repeated measures
data, and compare the LAGO design to its standard non-adaptive factorial and two-armed alternatives where
the intervention is fixed before the study commences. Once a LAGO study concludes, LAGO provides a
means to design interventions for new centers, scaling up and out, subject to the same class of goals, perhaps
contextually dependent. Methods will be applied to XCVD and PULESA-Uganda, another active CMCI trial led
by co-Investigator Longenecker for which contact PI Spiegelman serves as study statistician, allowing for this
trial to serve as a living laboratory for LAGO methods development. User-friendly, publicly available software
will be produced and disseminated, to facilitate use of these designs by practitioners.

Public health relevance
The use of complex, multi-component interventions has become an increasingly important strategy for cardiovascular disease prevention, screening and treatment, but in the face of the complexity of these interventions it is difficult to specify before a trial launches the optimal intervention package and its optimal intervention component “doses”, as existing non-adaptive and adaptive methods require. Previously, we established “Learn-As-you-GO” or LAGO designs for logistic regression for a single binary outcome, where the intervention package is increasingly refined within each successive stage, optimizing for cost-effectiveness and the attainment of pre-planned study goals. In this project, we will develop the mathematical theory and open- source software for adaptive LAGO designs for the range of outcome data typically encountered and across a number of design options not covered by our initial 2021 Annals of Statistics paper, focusing on cost- effectiveness, reaching a pre-planned study goal at pre-specified statistical power even when pre-trial expectations are not met, and comparisons of LAGO to existing non-adaptive designs, motivated by the EXTRA-CVD (U01HL142099) and PULESA-Uganda (UG3HL154501) studies, the latter of which is an ongoing NHLBI-supported project for which the contact PI serves as study statistician that is funded to apply LAGO at two pre-planned stages after baseline.